DP-21-001 Maryland Pregnancy Risk Assessment Monitoring System (PRAMS)

Pregnancy Risk Assessment Monitoring System (PRAMS) in Maryland
Executive Summary, July 2020
Background-The Maternal and Child Health Bureau and the Vital Statistics
Administration have worked jointly to implement the Maryland PRAMS project since
2000 through a cooperative agreement with the Centers for Disease Control and
Prevention (CDC). PRAMS surveys mothers 2-9 months after delivery about factors
before, during, and shortly after pregnancy that may have an impact on pregnancy
outcome. The program has also proven its capacity to implement survey supplements on
emerging issues including the influenza vaccine, Zika, disability, and opioid use.
The Maryland PRAMS survey booklet is sent monthly to a sample of new mothers
along with an incentive (manicure file). The survey questionnaire, as well as other
PRAMS materials, is available in both English and Spanish. Each mother is sent up to
three surveys followed by a telephone interview if no written surveys have been
returned. A $100 gift card is given out monthly to a mother chosen randomly who has
completed the mail or phone survey. Maryland currently utilizes a stratified random
sample based on infant birth weight (over-selecting mothers who have delivered a low
birth weight infant under <2500 grams).
Program Features-Maryland PRAMS data are analyzed annually and currently
include reports from 2001 to 2017 birth years. Focus Briefs on various topics are posted
on the PRAMS website at www.marylandprams.org. Human Subjects Training occurs
annually for all PRAMS staff and was last completed in July 2020.
Number of Mothers Served-Approximately 2,000 new mothers are surveyed
annually. As of June 2020, 44,714 new mothers in Maryland have been mailed the
PRAMS survey since its inception. Annual weighted response rates from 2001-2017
births have met or exceeded the threshold.
Budget-Maryland PRAMS is currently funded at $172,500 annually ($157,500 in core
funding and $15,000 in supplemental disability funding). We are currently in year five of
a five year cycle. This competitive application is for year one of the next 5 year grant
cycle. We will be requesting the ceiling award amount of $175,000.

Public health relevance
Project Narrative The Pregnancy Risk Assessment Monitoring System or PRAMS is a Centers for Disease Control and Prevention (CDC) supported surveillance initiative that works with state health departments to collect state-specific, population-based data on maternal attitudes and experiences before, during, and shortly after pregnancy. This population-based data provides a rich source of information, some not otherwise available, for maternal and child health programs and policy.